HealthMakers: Expanding Health Education Opportunities for Montana Youth

PROJECT ABSTRACT
Hopa Mountain, working in partnership with Montana State University (MSU), will
develop innovative and coordinated opportunities for Montana youth to strengthen
their STEM (Science, Technology, Engineering and Mathematics) skills and knowledge
while preparing them for higher education and careers in health sciences. The overall
project goal of HealthMakers is to support rural and tribal youth’s interest and exposure
to careers in the sciences while giving them the skills and resources to play leadership
roles in increasing healthy family practices in their homes and communities.
HealthMakers will achieve meaningful impacts annually through four strategies:
(1) Health-focused college preparation programs for 50 teens; (2) Summer academic
enrichment programs for 20 teens; (3) Community-based science literacy events for
2,000 children and their families, and (4) Professional development for educators,
community members, and parents. Hopa Mountain and MSU will engage youth,
educators, community leaders, and parents in training opportunities through
HealthMakers. Participants will take part in community-based workshops, college tours,
and summer institutes led by MSU faculty, healthcare professionals, Hopa Mountain
staff, and their peers. Through these strategic aims, HealthMakers will help create a
stronger workforce and inspire students to pursue careers in the sciences.

Public health relevance
NARRATIVE HealthMakers will support the development of health related outreach and college preparation programs and training resources to create a better informed workforce for Montana and inspire students to pursue careers in the sciences. These strategic aims and deliverables benefiting rural and tribal families and children, will help create a stronger workforce and inspire students to pursue careers in the sciences. Working together, Hopa Mountain and Montana State University will support rural and tribal youth’s interest and exposure to careers in the health sciences while giving them the skills and resources to play leadership roles in increasing healthy family practices in their communities.